The Role of the Bifidobacterium Gut Microbiome Guild in Pathophysiology of Chronic Heart Failure with Reduced Ejection Fraction

PROJECT SUMMARY/ABSTRACT
The candidate’s long-term career goal is to lead an independent research program focused on defining
mechanisms that govern gut microbiome-host interactions in chronic heart failure and to translate this
knowledge into novel preventative and therapeutic targets. This research program will pave the path for gut
microbiome-focused precision medicine approaches in heart failure.
The candidate will use the structured environment of the K08 award to acquire advanced research expertise in
microbiome meta-transcriptomic and time-series analyses, integrative multi-omic data analysis, clinical
research methods, as well as targeted professional development skills in mentorship, scientific communication,
grantsmanship, and leadership. This will be accomplished in the context of investigating longitudinal gut
microbiome-host interactions in chronic heart failure and how these relate to disease pathophysiology and
progression. The candidate will leverage a longitudinal multi-omic and clinical dataset from a cohort of 60
patients with chronic heart failure with reduced ejection fraction, previously recruited by the candidate as part
of her NHLBI-funded F32. The first aim will examine the relationship between gut microbial Bifidobacterium-
based functional guild and heart failure severity and outcomes. The second aim will elucidate shifts in the host
immune profile, gut microbiome composition and function, and heart failure disease status following a targeted
Bifidobacterium probiotic intervention. A new cohort of patients with stable chronic heart failure with reduced
ejection fraction will be recruited for this aim. This project will uncover mechanisms by which the gut
microbiome interacts with different facets of host biology, which is expected to provide novel insight into
disease pathophysiology and explain heterogeneity in heart failure progression. This knowledge will translate
into better disease risk stratification and identify new therapeutic targets in heart failure.
The proposed project will be performed under the guidance of an expert mentorship team comprised of world-
leading experts in host-microbiome multi-omics (Dr. Snyder), mechanistic microbiome research (Drs.
Sonnenburg and Tang), and heart failure translational research and clinical trials (Drs. Tang and Khush). They
will provide complementary expertise in skills applied in this project and support the candidate's career
development. The rich multidisciplinary environment at Stanford is optimal for this research proposal and
provides an ideal setting for the candidate’s development into an independent researcher. At the culmination of
this proposal, the candidate will gain the necessary expertise and preliminary data for an R01 proposal to
identify synergistic microbiome-host pathways that underlie heart failure pathophysiology. As an independent
physician-scientist, the candidate will use gut microbiome-based precision medicine approaches to improve the
outcomes of patients she cares for as a heart failure physician.

Public health relevance
PROJECT NARRATIVE The disease course of chronic heart failure, a prevalent disease with high morbidity and mortality, is highly variable and our ability to predict progression on an individual level and prevent it is limited. Data from animals suggests that the gut microbiome, a community of microbes living in our gastrointestinal tract, may play a role in heart failure pathophysiology and disease progression. The goal of this project is to better understand disturbances in the gut microbiome, its interactions with the host and their joint impact on heart failure pathophysiology and disease progression in patients with chronic heart failure, which will identify novel preventative and therapeutic targets and improve risk stratification in this disease.